Negative MAPK-RAS-ERK pathway regulation to sustain CIC-DUX4 expression

Project Summary/Abstract
Transcription factor (TF) fusion genes create oncoproteins that drive tumorigenesis. While TF fusions
represent cancer specific alterations, direct therapeutic targeting remains a clinical challenge. One
example is the CIC-DUX4 TF fusion which defines an aggressive subset of round cell sarcoma in
children and young adults. The clinical outcomes for CIC-DUX4 patients remain dismal due to high
metastatic propensity and ineffective therapies. Currently, no therapies exist that direclty target the CIC-
DUX4 fusion. To meet this need, we have recently identified a mechanistic link between the terminal
MAPK signaling substrate, ERK, and CIC-DUX4. Specifically, ERK physically binds and phosphorylates
CIC-DUX4 leading to rapid nuclear export, degradation of the fusion, and tumor cell death. Since MAPK
signaling is a ubiquitous pathway expressed in both normal and malignant processes, we wondered
how the CIC-DUX4 fusion could maintain its own expression. Through biochemical and molecular
studies we have identified a key role for negative MAPK-ERK regulation in CIC-DUX4 sarcoma cells.
Whereby, CIC-DUX4 transcriptionally upregulates the ERK specific phosphatase, DUSP6, to limit ERK
activity and thus enable CIC-DUX4 expression. More recently, we made an unexpected finding that
CIC-DUX4 expression could also downregulate RAS activity. Since RAS is a proximal MAPK substrate
not targeted by DUSP6, we hypothesized that CIC-DUX4 was limiting MAPK-RAS-ERK signaling flux
at multiple levels within this canonical signaling cascade. This proposal will define how CIC-DUX4 is
regulating RAS activity, thus further sustaining CIC-DUX4 expression.

Public health relevance
Project Narrative CIC-DUX4 sarcomas are a lethal subset of undifferentiated round cell sarcoma that impacts pediatric and adolescent young adults. There are currently no effective therapies for patients with CIC-DUX4 sarcoma. We aim to develop a mechanism-based approach to directly target the CIC-DUX4 oncoprotein.